CHEMICAL SCREENING AND OPTIMIZATION FACILITY - PROTEIN EXPRESSION AND/OR X-RAY CRYSTALLOGRAPHY

The Chemical Screening and Optimization Facility (CSOF) fulfills a unique role by identifying, optimizing and conducting production identified small molecules for contraceptive and reproductive health related (e.g., infertility, polycystic ovarian syndrome, fibroids, endometriosis, dysmenorrhea, adenomyosis, gynecologic and/or pelvic pain, and vulvodynia, premature birth, placenta health, improving lactation quality and quantity, preeclampsia, perinatal microbiome, gestational diabetes, inflammation, bacterial infections, viral infections, necrotizing enterocolitis, bronchopulmonary dyplasia, pre-term birth, fetal growth restriction, mastitis, Cushing's disease, Down Syndrome, Ricketts, Muscular Dystrophy, Rett syndrome, sepsis, or Autism) research. One approach is to perform x-ray crystallography studies with active target proteins or peptides in the presence or absence of chemical entities of interest. The research contained within this task order will encompass generation and purification of proteins or peptides of interest, development of crystals, and structural analysis by x-ray crystallography.